Core F -Clinical Science Core

CORE F: PROJECT SUMMARY/ABSTRACT. The Clinical Science Core provides support for clinical,
basic/translational, and behavioral investigators in the conduct of HIV-related research involving human subjects
at the University of California, Los Angeles (UCLA), Charles Drew University (CDU), and affiliated centers. The
goal of Core F is to support the translation of preliminary and pre-clinical data and ideas into clinical/human
studies that advance HIV science and lead to interventions with potential quantifiable impact on the HIV
epidemic. The Core will do this by reducing identified barriers to the development and implementation of patientoriented
research. The Core has two Specific Aims: 1. To provide support and training to investigators in the
regulatory approval and implementation aspects of biomedical, behavioral, and basic translational patientoriented
research in HIV, and 2. To facilitate patient-oriented research in HIV by increasing access to research
participants and generating new collaborations and concepts. The Core offers a streamlined process and
consultative services to reduce the time between project conception and funding (supporting clinical protocol
development and feasibility assessment for successful grant submissions); reduce the time between funding and
the initiation and completion of the research; train and support new investigators and established investigators
new to patient-oriented research in regulatory, design, and implementation aspects of human subjects research,
to move novel and efficacious interventions from the lab to the clinic (domestically and globally); support
mechanistic work that can lead to clinical interventions by increasing access to human samples; promote
collaboration through linkage to HIV research networks and data; and engage underrepresented populations in
HIV research through the Research Study Volunteer Project (RSVP), a Core-sponsored volunteer registry for
individuals with and without HIV interested in participating in HIV-related research, to generate the most
informative prevention and treatment studies in key populations. All services of the Core will support both
domestic and internationally based research initiatives.